Infections and the Stability of Transplantation Tolerance

Overall Summary
Transplantation tolerance, a state of hyporesponsiveness to donor antigens after cessation of therapy, is an
attractive approach for achieving life-long graft acceptance without global immunosuppression. Tolerance is rare
in the clinic, and even when attained can be lost over time, sometimes after infections. Understanding the barriers
to the induction of transplant tolerance in the clinic, and the vulnerabilities to durable tolerance, is essential to
achieving the goal of one transplant for life. One barrier to the induction of transplant tolerance in the clinic is T
cell memory (Tmem). The intrinsic independence of Tmem from costimulation and their resistance to Tregs can
explain the difficulty in inducing tolerance. Project 2 has identified an additional hurdle by which Tmem can
antagonize the induction of transplant tolerance: a small number of Tmem can “infect” naïve T cells into acquiring
memory-like features and resisting costimulation blockade (CoB) via a process of ‘linked-sensitization’.
Once established, transplantation tolerance may exhibit vulnerabilities to its maintenance especially during
settings of proinflammatory infection. Project 1 has identified heterogeneity in states of dysfunction achieved by
polyclonal alloreactive T cells following CoB, with T cells specific for alloantigens that are rapidly downregulated
in the graft following transplantation, and T cells with low affinity/avidity to graft antigens, retaining function
despite CoB. These functional T cells do not pose a threat to the graft at steady state because they are controlled
by Tregs. However, inflammatory cytokines elicited by some infections are known to destabilize Tregs, activate
APCs and upregulate graft MHC, such that these T cells that retain function may mediate graft rejection.
Both projects have identified a solution to these barriers/vulnerabilities. Project 2 found that exposing donor-
reactive Tmem to a semi-allogeneic pregnancy re-programs Tmem into becoming susceptible to CoB. Project
1 shows that repeated injections of donor splenocytes can induce dysfunction in a wider repertoire of alloreactive
T cells, including Tmem. The molecular mechanisms underlying the acquisition of dysfunction will be investigated
and compared between projects, thus underscoring the synergy of the projects. The global hypothesis of the
current submission is that understanding the mechanisms by which linked sensitization and heterogeneity in
alloreactive T cell dysfunction prevent tolerance induction or break established tolerance, as well as the
mechanisms by which exposure to pregnancy or to repeated donor splenocyte injections overcome these
barriers, will help identify critical molecular drivers of tolerance, markers of robust versus unstable tolerance, and
aid in the design of new therapeutic approaches to induce durable transplantation tolerance. Project 1 addresses
the mechanisms by which the duration of alloantigen expression determines the level of T cell dysfunction post-
CoB (Aim 1) and tests the hypothesis that low affinity/avidity alloreactive T cells are poised to mediate rejection
during infections (Aim 2). Project 2 investigates the mechanism behind linked sensitization (Aim 1), and how
CD8+ (Aim 2) and CD4+ (Aim 3) alloreactive Tmem are re-programmed by pregnancy.

Public health relevance
Overall Narrative Transplantation tolerance, a state of immune hyporesponsiveness to a graft following cessation of immunosuppressive therapy, can prevent complications from life-long global immunosuppression but is rarely attained in the clinic. This PPG addresses the barriers to both the induction and long-term maintenance of transplantation tolerance, and explores two potential solutions that leverages the natural ability of pregnancy to tolerize fetus-reactive T cells and harnesses the capacity of chronic antigen exposure to drive immune hypofunction.